Decoding Prior Bias in Psychosis Using Population Receptive Fields

PROJECT SUMMARY
Schizophrenia is an exceedingly prevalent and burdensome illness that affects ~26 million individuals
world-wide and accounts for ~16 million years of life lost due to disability per year. A characteristic symptom of
schizophrenia is auditory hallucinations, occurring in ~80% of patients with ~30% of sufferers unresponsive to
available treatments. Despite their impact, the neural mechanisms of auditory hallucinations are poorly
understood. Auditory hallucinations are thought to arise from greater bias towards prior knowledge when
forming perceptions (prior bias). Prior bias is the incorporation of prior knowledge into percepts that biases
perception towards more likely sensory events. Previous studies using single-unit recordings during perceptual
decision-making tasks have probed the neural manifestation of prior bias. A major finding of this work is that
behavioral bias for a stimulus feature (e.g. leftward motion vs rightward motion) is associated with greater
activity in neurons with receptive fields tuned to that stimulus feature. To probe the neural mechanisms of
prior bias it is thus critical to define the tuning of receptive fields and design experiments that
capitalize on this tuning (Aim 1). Population receptive field (pRF) mapping is a novel fMRI method that
allows definition of neural tuning in auditory and visual regions with tonotopic and retinotopic organization,
respectively. For example, tonotopic pRF mapping can define regions that are macroscopically organized with
ensembles of neurons tuned to a specific tone frequency. By combining tonotopic pRF with a behavioral
task to probe perceptual biases in tone frequency a direct measurement of the neural mechanisms of
prior bias in auditory hallucinations can be developed (Aim 2).
In Aim 1 we will use pRF tonotopic mapping to define the tonotopic organization of the auditory cortex in
unmedicated patients with schizophrenia (N=30) and investigate differences compared to matched healthy
controls (N=30). We hypothesize that the severity of auditory hallucinations will be correlated with broader pRF
tuning in the associative auditory cortex. In Aim 2 we will determine the neural representation of prior bias in
auditory hallucinations by acquiring fMRI during a two-tone frequency discrimination task in the same
unmedicated schizophrenia patients and matched healthy controls from Aim 1. This task elicits prior bias that
will be directly measured by using the tonotopic maps acquired in Aim 1 to localize activation to specific
frequencies. We hypothesize that prior bias will manifest in the fMRI signal as an over-activation of the pRF's
tuned to the prior information and that the degree of over-activation will correlate with the severity of auditory
hallucinations.

Public health relevance
PROJECT NARRATIVE The psychotic syndrome of schizophrenia (including auditory hallucinations) remains among the most incapacitating and burdensome conditions worldwide, particularly for a substantial portion of patients (~1/3) whose symptoms do not improve sufficiently with currently available treatments; psychosis is perhaps the most puzzling state in clinical neuroscience. By leveraging new computational, statistical, imaging, and behavioral tools, this project aims to provide a novel method to directly measure the neurobiological mechanisms of behavioral abnormalities that manifest as auditory hallucinations. This will advance our understanding of auditory hallucinations by identifying core neural processes that can be targeted via novel patient-tailored plasticity and feedback-based treatments.